Metabolic regulators of Treg/Th17 balance in CNS autoimmunity

PROJECT SUMMARY/ ABSTRACT
Autoimmune tissue inflammation is dictated by a balance between effector and regulatory T cells.
During an autoimmune reaction, effector T cells hyper proliferate, produce pro-inflammatory cytokines
and suppress expansion and generation of regulatory T cells resulting in inflammation. Cytokines play
a key role in the process, but other factors such as metabolism and physical factors like oxygen tension,
pH and space in tissue microenvironment play an equally important role in regulating effector vs. Treg
balance. However, the analysis of T cell metabolism in tissue is challenging due to limitations of
available cell numbers and current metabolic techniques. We developed a novel computational
algorithm called Compass that can predict metabolic state of cells using single cell RNAseq data.
Facilitated by this tool, we identified polyamine metabolism as a major driver of pathogenicity of Th17
cells. Herein we observed that Odc1 inhibition can regulate mitochondrial function by increasing
mitochondrial complex stability genes with potential consequences in effector T cell function. Further,
our preliminary data suggests a connection between the polyamine pathway (rate limiting enzyme,
Odc1) and an epigenome modifier, JMJD3/Kdm6b. We also provide evidence that inhibition of the
Odc1-JMJD3 axis by chemical inhibitors or genetic deletion modifies the transcriptome and epigenome
(genome accessibility) of Th17 cells in favor of Tregs with relevance in tissue inflammation in CNS in
experimental autoimmune encephalomyelitis (EAE). Based on these data we hypothesize that
polyamine pathway is a critical metabolic and epigenetic regulator of effector vs. Treg differentiation
and thereby affects development of tissue inflammation. The key element of the pathway, Odc1-
JMJD3 axis is a checkpoint that can be regulated by cytokines and can sense environmental
cues such as hypoxia and subsequently adjust metabolic and epigenomic state of T cells to
regulate effector vs. regulatory T cell balance. We will test this hypothesis in two aims: 1) determine
how polyamine biosynthesis restricts mitochondrial oxphos and promotes reverse electron transport to
impact effector vs. Treg development in inflamed CNS during EAE; 2) determine whether polyamine
metabolism enzyme Odc1 interferes with JMJD3 function to modulate the genome accessibility of T
cells favoring Th17 over Treg development during EAE development. The polyamine metabolism
pathway likely has broader implications in T cell biology. Hence, we will focus on the relevance of the
Odc1-JMJD3 axis in inflamed CNS in the context of Th17/Treg balance. The proposed study is highly
relevant in human diseases as reflected by a significant overlap (about 25%) between multiple-
sclerosis risk variants and genes that differentially regulate effector Th17 vs. Treg differentiation.

Public health relevance
NARRATIVE Autoimmune tissue inflammation is dictated by a balance between proinflammatory effector T cells and tissue protective FoxP3+ regulatory T cells. The factors besides cytokines that regulate the balance between Tregs and Th17 are beginning to be elucidated. By developing a novel computational algorithm Compass, we have identified polyamine pathway as a major metabolic driver the dictates the balance between Treg and Th17 cells. The proposal will focus on understanding the role of polyamine metabolism, mitochondrial respiration, and demethylase Jmjd3/Kdm6b at a molecular level by analyzing changes in transcriptome, metabolome, and epigenome.